Extracellular matrix proteoglycans regulate toll-like receptors 4 and 9 - Equipment Supplement

Pseudomonas (P.) aeruginosa bacterial infections cause sight-threatening inflammation of the cornea. With
antibiotic resistance on the rise, additional treatment strategies are needed. To address this gap, the current
proposal focuses on novel interactions of pathogen recognition toll-like receptors (TLRs) with lumican (Lum),
an extracellular matrix protein of the cornea. The TLR-4 and TLR-9 receptors recognize P. aeruginosa cell wall-
derived lipopolysaccharides (LPS) and nuclear DNA, respectively, to induce pro-inflammatory cytokines and
type I interferons. LPS recognition by TLR4 at the cell surface of macrophages and dendritic cells (DCs) leads to
MyD88-dependent pro-inflammatory cytokine production, while endosomal TLR4 stimulates an alternative
pathway that additionally produces type I interferons. Endolysosomal TLR9, on the other hand, stimulated by
bacterial DNA or the synthetic TLR9 ligand CpGDNA, leads to the production of both pro-inflammatory
cytokines and type I interferons. Interestingly, Lum has opposing effects on the TLR4 and TLR9; it promotes
TLR4 but suppresses TLR9 responses. We demonstrated that a tyrosine at the N-terminal end (Y20) of Lum
binds with the TLR-adaptor CD14 to promote cell surface TLR4 signals. Our preliminary data suggest a potential
caveolin-1 binding site at the C-terminal end (F228) of Lum that may be involved in caveolar trafficking of TLRs.
Our central hypothesis is that through binding CD14 and CAV1 Lum regulates TLR4 and TLR9
locations within cells to promote TLR4 but restrict TLR9 signals, and this will impact pro-
inflammatory cytokine and type I interferon inductions to modulate inflammation and regain of
tissue homeostasis in keratitis. In the following aims we will test our hypothesis using wild type mice, Lum-
null mice, and their macrophages and dendritic cells; Aim 1) determine if Lum regulates TLR4 location and
degradation, with CD14-binding preferentially promoting the cell surface while CAV1 the endosomal TLR4
pathway, Aim 2) test if Lum increases the inactive TLR9 pool in cell surface and endosomal compartments to
suppress its signals, and Aim 3) determine the course of sterile keratitis mediated by LPS or CpGDNA and P.
aeruginosa mediated infectious keratitis in Lum-deficient and wild type mice and the effects of subconjunctival
injections of mutated recombinant Lum with loss of CD14 or Cav1 binding activity. Type I interferons have broad
antibacterial and tissue protective roles in addition to their well-known antiviral properties. Thus, a provocative
translational potential is that by manipulating the CD14 and the CAV1 binding properties of Lum, it will be
possible to regulate the pro-inflammatory cytokine and type I interferon induction pathways separately to resolve
inflammation and expedite corneal healing keratitis.

Public health relevance
Pseudomonas infection of the cornea is a common cause for sight-threatening inflammation of the eye. With antibiotic resistance on the rise additional treatment options are needed. We identified novel interactions between corneal extracellular matrix proteins and host pathogen recognition receptors that we propose to investigate for future development of treatment strategies for inflammation and corneal tissues damage.